Antigen recognition and activation of B-cell receptors of HIV-1 broadly neutralizing antibodies

Project Summary/Abstract
Elucidating the early events on the B cell surface following antigen engagement of the B cell antigen receptor
(BCR) can provide an assessment of the in vivo potential of an antigen (Ag) to drive B cell activation. In contrast
to the “clustering model”, the “Dissociation Activation Model” (DAM) proposes an alternate conformational state
of the resting BCR and how early events on the B cell membrane initiates B cell activation. In the DAM, B cell
activation is dependent on the ability of an Ag to dissociate the inactive, resting BCR oligomers (BCR
conformational opening), and promote nanoscale reorganization of BCR with co-stimulatory molecules, leading
to full activation. Recent advances in HIV-1 Envelope (Env) protein designs have provided several key potential
immunogens, however, how such viral Ags are sensed by BCRs on B cells that participates in anti-HIV-1
immune responses that generate broadly neutralizing antibodies (bnAbs) is not well understood. The overall
objective of this proposal is to bridge the quantitative biophysical and membrane dynamics measurements of
Ag-BCR interactions to ex-vivo and in-vivo B cell activation in the context of the DAM. Towards this goal, we will
for the first time, study and define at nanoscale resolution, Ag-induced early BCR activation events and the
costimulatory signaling required for full activation of B cells expressing BCRs specifying prototype HIV bnAbs or
their precursors. We hypothesize that for optimal priming HIV Env immunogens, i.e. those capable of best
activating B-cells and initiating robust affinity maturation, the exposure of the BCR to the Env antigens results
first in nanoscale BCR conformational opening, followed by reorganization of BCRs and co-stimulatory
molecules/kinases for signal amplification on the B cell membrane. In Aim 1, we will perform biophysical
analyses and study B cell membrane dynamics to define the properties of HIV Env Ag-BCR interactions for
optimal activation of B cells expressing bnAb or germline precursor BCRs. In Aim 2, we will use high resolution
assays to determine Ag-binding properties that induce nanoscale BCR conformational opening, the role of
costimulatory and regulatory molecules and the spatio-temporal reorganization of the B cell membrane following
activation with HIV Env Ags. In Aim 3, we will test evaluated Env Ags for their ability to activate and drive
affinity maturation in “more amenable to induce”, (non-anergic or more “mildly” anergic) bnAb B cells in naïve
knock-in (KI) repertoires. Results of such studies would be the first to allow a systematic method for predicting
the potential of HIV immunogens to prime distinct bnAb precursors based on these defined Ag-induced early B
cell activation events. In the long-term our studies will facilitate design and pre-selection of immunogens for
testing in animal models and accelerate HIV-1 vaccine development.

Public health relevance
Project Narrative We will study how HIV-1 Envelope proteins of varying affinities are sensed by B cells expressing HIV-1 bnAbs (broadly neutralizing antibodies) against key vaccine targets and initiate early signaling events for their activation. Using high-resolution assays, and relevant B cell lines as well as B cells from knock-in mice expressing HIV bnAbs or unmutated precursors as B cell antigen receptors (BCRs), we will define the key properties of BCR-antigen interactions and early nanoscale B cell membrane events that promote co- stimulation and optimal B cell activation.